CHOLESTASIS IN NEONATES--RE ACID INFUSION VS STANDARD AMINO ACID SOLUTION

This gastroenterology protocol is a comparison of cholestasis in neonates re-acid infusion formulated for neonates vs. standard amino acid solution therapy.